The role of 24-hour activity cycles in preserving cognitive function and preventing Alzheimer's disease and related dementias

ABSTRACT
Alzheimer’s disease and related dementias (ADRD) are the 6th leading cause of death in the U.S and is
prevalent in ~6 million U.S. adults. Without effective prevention strategies, ADRD prevalence is expected to
triple by 2060. The lack of successful pharmacologic treatments for clinical ADRD necessitates a call-for-action
to identify modifiable factors that preserve cognitive function and prevent ADRD. Moderate-vigorous intensity
physical activity (MVPA) has been identified as a key strategy that could have the greatest non-pharmacologic
impact on the projected ADRD epidemic. However, MVPA corresponds to only a small portion of the 24-h day
(~2%). The other movement behaviors that comprise the remaining ~98% of the 24-h day, including sedentary
behavior (SB), light physical activity (LPA), and sleep, constitute additional modifiable considerations. Growing
evidence suggests that the combined effects of these movement behaviors may be greater than their individual
effects. Thus, focusing efforts on a single factor (e.g. MVPA) limits efficacy. Appropriate levels of MVPA, LPA,
SB, and sleep may need to be achieved simultaneously (e.g. a “healthy 24-hours”) for optimal resilience to
adverse cognitive outcomes. Yet little work has characterized the role of the 24-h activity cycle to preserve
cognition and prevent ADRD. To address this critical research gap, we propose an ancillary study to the
ongoing REasons for Geographic And Racial Disparities in Stroke (REGARDS) study. The overall goal of this
project is to characterize the temporal, bidirectional relationship between the 24-h activity cycle and adverse
cognitive outcomes. Specifically, we will test whether: 1) composition of the 24-h activity cycle predicts change
in cognitive function and incident mild cognitive impairment (MCI) or dementia, 2) cognitive function and
prevalent MCI/dementia predict change in composition of the 24-h activity cycle, and 3) change in the
composition of the 24-h activity cycle is associated with change in cognitive function and transitions in cognitive
impairment status. We will also determine the most beneficial 24-h activity cycle compositions associated with
a lower risk of cognitive impairment. To address our aims, we will leverage the exceptional resources of
REGARDS, including assessment of cognitive function at annual and biennial intervals, algorithmic
classifications of MCI and dementia, and collection of objective measures of the waking components of the 24-
h activity cycle from 2009-2013. In this ancillary study, we propose to augment REGARDS with a 7-day
accelerometer and sleep actigraphy protocol to objectively measure the 24-hour activity cycle (SB, LPA,
MVPA, and sleep). By elucidating the temporal, bidirectional relationship between the 24-h activity cycle and
cognitive function and identifying beneficial 24-h activity cycle compositions, this project will address existing
evidence gaps and provide empirical evidence to accelerate a paradigm shift towards an integrated model that
incorporates all 24-hour movement behaviors to optimize cognitive health.

Public health relevance
PROJECT NARRATIVE As the 6th leading cause of death in the U.S. and one of the major causes of disability and dependency among older adults, Alzheimer’s disease and related dementias poses a significant public health burden– thus necessitating a need to identify modifiable behaviors that can be targeted for intervention to preserve cognitive function. To address this need, this study will use state of the art measures and analytic procedures to prospectively evaluate the temporal, bidirectional relationship between the 24-h activity cycle and cognitive health. Findings will elucidate the role of waking and sleep behaviors and their collective combinations over a 24-hour day on resilience to adverse cognitive outcomes and identify beneficial 24-h activity cycle compositions for perseveration of cognitive function; information critical for establishing more personalized behavioral targets for future trials and public health guidelines.